BLRD Research Career Scientist Award Application

The overarching objective of the Aguiar laboratory is to improve our understanding of cancer
biology, in particular the molecular and cellular basis of B cell lymphomas development and
progression with the intent of translating these discoveries into clinical activities. The Aguiar
laboratory uses in vitro and in vivo systems, in genome-wide or focused approaches, to
investigate the pathogenesis of diffuse large B cell lymphoma (DLBCL). DLBCL is the most
common B cell cancer in adults, with ~25000 new cases diagnosed yearly in the US alone.
Importantly, DLBCL remains incurable in ~40% of the patients, and the last time that this
suboptimal cure rate was improved, it was 20 years ago with the addition of rituximab (anti-CD20
antibody) to classical chemotherapy. Thus, the field has coalesced around the concept that to
improve DLBCL outcome, we first need to better understand this disease biology, and impact on
its clinical heterogeneity. Towards this end, the Aguiar group currently has three active lines of
investigation: 1) the Aguiar lab is examining the interplay between mitochondrial metabolism and
epigenetic modulation. In this area of knowledge, they recently made substantial contributions.
First, they discovered that a subset of DLBCLs harbor loss of function mutations in D2HGDH,
which encodes a mitochondrial enzyme that converts the natural metabolite D-2-HG into alpha-
ketoglutarate (αKG). The main consequence of these mutations is depletion of the cellular pool
of αKG and hypermethylation (DNA/RNA/histone). Subsequently, the Aguiar lab showed that
MYC, a central lymphoma oncogene, regulates D2HGDH expression and thus, via modulation of
intermediary metabolism, can modify the cellular epigenome. The ultimate objective of this broad
research activity is to test the concept that αKG supplementation possess anti-lymphoma
properties, an idea that the Aguiar lab has already validated pre-clinically. 2) The Aguiar research
program is also invested in expanding and further credentialling phosphodiesterase 4 (PDE4) as
an actionable therapeutic target in mature B cell malignancies. This is a long-standing research
line in their group, which started with the discovery that the expression of the gene PDE4B was
uniquely elevated in fatal DLBCL cases. Subsequently, in a collection of impactful publications
across a decade of pre-clinical work, the Aguiar lab showed that high PDE4 expression and
activity blunts the inhibitory effects of cyclic-AMP towards the B cell receptor (BCR), which thus
remains abnormally active in DLBCL. The Aguiar laboratory then discovered that this oncogenic
signal can be turned off with PDE4 inhibitors, a concept that they validated in two recent
completed clinical trials. A third, pivotal randomized phase 2 trial has been open and will start
accruing in the fall. In this study, Dr. Aguiar and his clinical co-leaders aim to confirm the benefit
of adding PDE4 inhibitors to the first line treatment of DLBCL. 3) Another active research line in
the Aguiar group relates to the impact that lymphoma cell intrinsic programs may have on the
tumor microenvironment. Their focus here is on somatic mutations found in transcription factors,
which unexpectedly perturb antigen presentation and anti-cancer immunity. These studies have
the potential to identify patients that may be particularly responsive to immune checkpoint inhibitor
agents. Taken together, with a focus on a common and often fatal cancer type, the Aguiar
laboratory is working on multiple aspects of basic lymphoma biology all of which converge towards
concrete clinical applications.

Public health relevance
Lymphoma is a cancer type that originates from lymphocytes, cells present in the bloodstream and specialized organs such as the spleen, bone marrow and lymph nodes. Lymphoma is more frequently diagnosed in veterans than in the civilian population. This higher incidence is thought to be related to toxic environmental exposures in the battlefield. The Aguiar research group studies the mechanism for lymphoma development and progression, with special emphasis on the basis for the disease’s heterogeneity, that is, why patients with similar tumor burden receiving similar treatment may have very differently outcomes, and either survive or die of their disease. Importantly, the research in the Aguiar lab is geared towards clinical translation, meaning that the discoveries from the laboratory are as expeditiously as possible brough to the “bedside”, in a manner that treatment can be rationally modified, and the cure rate improved.